AIDS PREVENTION TRAINING FOR MINORITY PARENTS

Because there is no known cure for AIDS, nor any cures currently anticipated, the most effect response to this international epidemic must be through education and prevention. Unfortunately over a third of United States youths in large cities have abandoned school, and in conducting their lives in the context of street culture are at high risk for contracting AIDS. Phase I of this proposal aims to develop and to refine a training package for delivery to parents of inner city minority youth in the 9 to 12 year age range, using established church-related channels of communication which have been previously employed in delivering educational programs concerning the related problems of drug use and teen-age pregnancy. A prototype curriculum, with training manual and supporting videotape material, is the end product of the proposed Phase I feasibility study. Evaluation will focus upon medical, education, statistical and sociological validity issues, and upon the generalizability of the product to a wider target population. Phase II will focus upon developing a marketable program package for wide dissemination to governments, education institutions and other organizations.